Glial Control of Neuron Development and Function - Administrative Supplement

Our long-term goal is to understand how glia contribute to nervous system development, function, and
information processing. Glia constitute a large fraction of cells in the vertebrate nervous system and surround
neuronal receptive endings to form isolated compartments. Most excitatory synapses are glia-ensheated, as
are sensory-neuron receptive endings and neuromuscular junctions. Major gaps remain in our understanding
of glia. While developmental specification of some glia has been explored, programs governing astrocyte or
sensory organ glia differentation are not clear. How glia form and regulate compartments around synapses and
other neuronal receptive endings is also not understood. Glia have been proposed to regulate neuronal
activity, yet the effector mechanisms are not fully explored. Finally, neuron structural and functional plasticity
may, in part, be under glial control, yet the details are not at hand. Thus, much remains to be learned about
glial functions and their underlying molecular programs. In many animals, neurons are born in excess, and the
final neuronal complement is determined in part by glial and other secreted cues controlling cell death. Glial
manipulation, thus, often leads to neuronal demise. A long-standing goal has been to identify in vivo settings
for studying glia-neuron interactions that bypass the neuron-survival problem. We have taken a major step
towards this goal by pioneering the nematode C. elegans as a facile and relevant system for studying glia and
their nervous system contributions. We showed that C. elegans possess glia, and that these ensheath
sensory-neuron receptive endings, highly resembling glial structures found in vertebrates sense organs, as
well as envelop the CNS, wrapping around defined synapses. Like vertebrate astrocytes, these latter glia tile,
subsuming specific CNS domains, express transcription factors promoting gliogenesis in vertebrates, and
express ion and neurotrasmitter transporters, channels, and neurotransmitter receptors. The development of
these glia bears uncanny similarities to the radial glia-to-astrocyte developmental transition in vertebrate brain
development. Importantly, in C. elegans, neuron survival does not require glia, but glia manipulation results in
major deficits in neuron shape and function. C. elegans therefore offers a unique in vivo arena to study glia and
their effects on the nervous system. Here we aim to investigate three interrelated aspects of glia-neuron
biology. (1) We will determine how astrocytic glia develop and regulate synaptic function. (2) We will determine
glia guide brain assembly. (3) We will study a new cell death program resembling glia-dependent
neurodegeneration. In addressing these questions we challenge the view that only neurons underlie the
phenomena under study, and posit that glia are integral regulators.

Public health relevance
Our long-term goal is to understand how glia contribute to nervous system development, function, and information processing. We have shown that glia play key roles in regulating neuronal shape and function in the nematode C. elegans. Here we will test the idea that glia are important regulators of synaptic function, and brain assembly, and study a new form of cell death with relevance to the nervous system. Our studies have broad implications for understanding glia-neuron interactions in all animals, including humans.